Molecular Basis of Pregnancy Complications in the Antiphospholipid Syndrome

The antiphospholipid syndrome (APS) is an autoimmune disease characterized by the production of
antiphospholipid antibodies (aPL) that promote adverse pregnancy outcomes including fetal loss, premature
birth, intrauterine growth restriction (IUGR), and maternal hypertension during pregnancy. Whereas treatment
with heparin has improved the rate of live births in APS patients with recurrent pregnancy loss, the incidence of
pregnancy complications remains high. As such, more effective mechanism-based therapies are urgently
needed. Previously we showed that pregnant mice globally lacking apolipoprotein E receptor 2 (apoER2) are
protected from the fetal loss and IUGR induced by the administration of aPL isolated from APS patients. We
also revealed in cultured trophoblasts that via recognition of the cell surface protein β2GPI and its interaction
with apoER2, aPL inhibit stimulatory Akt phosphorylation, leading to decreased cell proliferation and migration.
More recently, we discovered that aPL potently activate the serine/threonine protein phosphatase 2A (PP2A) in
cultured human trophoblasts, in mouse placenta in vivo, and in human placental explants ex vivo. We further
found that the PP2A inhibitor Cantharidin prevents aPL inhibition of cultured trophoblast cell growth and
migration. Based upon these novel findings, the overall goal of the proposed project are to determine how
aPL cause fetal loss, IUGR and maternal hypertension through impairment of trophoblast function, and to
test whether pregnancy outcomes are improved by novel interventions directed at these mechanisms. Aim
1 will determine whether and how trophoblast apoER2 and its adaptor molecules contribute to aPL-induced
fetal loss and IUGR using trophoblast-specific loss-of-function mouse models in vivo and human trophoblasts
in culture. Aim 2 will investigate the role of trophoblast PP2A in aPL-induced fetal loss and IUGR in vivo using
genetic and pharmacological loss-of-function approaches in mice. We will also identify the trophoblast genes
impacted by aPL treatment through PP2A activation in vivo, using our recently-established method to
selectively isolate ribosome-associated RNA in mice. Aim 3 will elucidate how aPL induce maternal
hypertension. Recently we determined that aPL administration promotes hypertension in pregnant mice, and
that aPL stimulate the secretion of soluble Flt-1 (sFlt-1) and soluble Endoglin (sEng) from cultured trophoblasts
in an apoER2- and PP2A-dependent manner. We will determine whether stimulation of sFlt-1/sEng secretion
caused by aPL activation of apoER2-PP2A in trophoblasts underlies the blood pressure elevation, using the
mice with trophoblast specific deletion of apoER2, PP2A or sFlt-1/sEng. We will also test if aPL-induced
maternal hypertension can be prevented by the administration of a unique monoclonal anti-β2GPI blocking
antibody that we identified prevents aPL-induced fetal loss, or a PP2A inhibitor. Accomplishing these aims will
lead to better understanding of the pathogenesis of obstetric APS and the development of mechanism-based
therapies to protect the fetus, as well as the mother, from this potentially life-threatening disorder.

Public health relevance
Project Narrative The goals of the proposed research project are to elucidate the molecular basis of APS-related pregnancy complications using cultured cells and a series of complementary mouse models and to further test novel interventions directly based on these pathogenic mechanisms. We anticipate that the new knowledge gained will then be translated into new prophylactic or therapeutic strategies to combat the devastating impact of APS. Considering the staggering impact of pregnancy complications on the patients suffering from APS, the goals of the research project are in line with the objectives of the National Institute of Health to address these disorders through medical research.